Continuity of Feed Contaminant Surveys: FDA CVM Vet-LIRN

Project Summary/Abstract The current project will follow up on the 2018 Feed Contaminant Survey through review of the design, implementation, and results of the 2018 survey, acquisition of feedback, and development of recommendations for the continuation of future feed surveys. This will provide the continuity required to monitor feed contamination events in support of national capacity/capability development, and to help guide methods development and validation projects. The Objective of this Capacity-Building agreement is to support enhanced human and animal food safety by developing a set of recommendations that will provide the framework needed to establish consistent, periodic, nationwide surveys of contaminants in animal feeds. The results of these future surveys can then be utilized to support national capacity/capability development and help guide methods development and validation projects ultimately strengthening food safety laboratories and networks. This will facilitate an effective and coordinated response to future human and animal food safety issues. One Aim is to review the objectives, format, implementation, analysis, and results of the 2018 Feed Contaminant Survey, obtain feedback from the veterinary diagnosticians (toxicologists and microbiologists) and from Vet-LIRN program staff. Recommendations for the continuation of feed surveys will provide the continuity required to monitor feed contamination events in support of national capacity/capability development, and to help guide methods development and validation projects. These will be prepared and submitted to the CVM Vet-LIRN. An additional aim will be to hire students to work on the compilation of feedback, and on diagnostics-related feed contamination. This will expose these students to feed contaminant-related veterinary diagnostic toxicology at the Purdue ADDL stimulating long-term interest in this fascinating field.

Public health relevance
Project Narrative This project is important to the protection of U.S. Public Health because it will support enhanced human and animal food safety by developing a set of recommendations that will provide the framework needed to establish consistent, periodic, nationwide surveys of contaminants in animal feeds. This will provide critical information that can be utilized to improve national capacity/capability development and help guide methods development and validation projects thereby strengthening food safety laboratories and networks. In addition, this project will hire students to work on the compilation of feedback gathered to develop the recommendations, and expose them to feed contaminant-related diagnostic veterinary toxicology stimulating long-term interest in this critical field.